NEUROTOXICITY OF SELECTED DRUGS TO MONOAMINE NEURONS IN BRAIN

The effects of selected drugs on monoamine neurons in brain has been examined. Fenfluramine, in high doses, has been found to decrease monoamine uptake sites in rat brain suggesting a neurotoxic effect at these high doses. The pharmacokinetics, and regional specificity as well as the time course of these effects have been examined. Also, DSP-4 has been shown to have different effects on norepinephrine uptake in the cerebral cortex versus the hypothalamus. These studies provide evidence for a heterogeneity of norepinephrine sites.